Mechanisms of autoimmunity in myasthenia gravis

Project Summary. Myasthenia gravis (MG) is an autoimmune disorder affecting neuromuscular transmission.
MG patients suffer from severe muscle weakness and increased muscle fatigability due to diminished
neuromuscular signaling. MG is caused by autoantibodies that target components of the neuromuscular junction
(NMJ); in most patients this is the nicotinic acetylcholine receptor (AChR). These AChR autoantibodies mediate
pathology through three mechanisms: (i) interfering with acetylcholine docking, (ii) internalization of the AChR,
and (iii) activation of the classical complement cascade leading to tissue damage. There is heterogeneity within
the AChR disease subtype that includes early-onset and late-onset MG (EOMG and LOMG), which is based on
age of onset, sex, and HLA-association.
Although MG patients with different subtypes share similar disease presentations, the underlying
immunopathology may be distinct. This is well Illustrated by the AChR EOMG and LOMG subtypes. Notably,
EOMG is characterized by a thymic lymphocytic infiltrate, which includes AChR-specific IgG, T cells, and B cells
(including AChR autoantibody-producers) that organize as tertiary lymphoid organs, resembling germinal
centers. In contrast, LOMG rarely includes thymic abnormalities. While details of the heterogenous
immunopathology are lacking, a deeper understanding of the mechanisms underlying the differences is highly
important for both the patient and clinician. This is because treatments that are anticipated to work well in one
subtype may not have a biological basis for use in the other subtype(s). Non-responding AChR MG patients in
a number of recent clinical trials, including B cell depletion, and complement inhibition therapies, clearly highlight
this gap in our knowledge.
Thus, in this renewal period we will investigate details of the divergent immunomechanisms underlying the
EOMG and LOMG MG subtypes. Our study is sharply focused on the B cells that directly contribute to disease
pathology, those which produce AChR autoantibodies. Using new approaches, we will isolate these rare AChR
autoantibody producing B cells from thymus tissue and blood and define their repertoire characteristics. Human
recombinant monoclonal antibodies (mAb) will then be produced from these B cells so that molecular
mechanisms of pathology can be defined using a suite of novel assays to identify their ability to affect pathology
through complement-directed tissue damage, blocking, or modulation. Finally, we will define the phenotypes of
autoantibody-producing B cell subsets and T helper cell subsets including those specific for the AChR antigen.
This study is designed to provide detailed insights into both the role of autoantigen-specific immune cell
subsets and molecular mechanisms used by autoantibodies to facilitate the pathology of the EOMG and LOMG
subtypes. These clearly defined immunomechanisms are expected to impact treatment outcomes through
informing application of biological therapeutics used to treat specific MG disease subsets.

Public health relevance
Project Narrative (relevance to public health) This study is aimed at further understanding immunological events that underlie the pathology of human neurologic autoimmune disease. The investigation will use novel molecular approaches to dissect the mechanisms of heterogeneous autoantibody-mediated pathology, and cellular approaches to further understand the differentiation and function of B cells and T cells that contribute to the production of autoantibodies. Specimens derived from patients with myasthenia gravis (MG), a chronic, disabling neurological autoimmune disease, will be studied; yet it is anticipated that the findings will define both clinically relevant biomarkers and highly specific treatment targets for similar autoimmune diseases.